CONF ON RADIOIMMUNODETECTION AND RADIOIMMUNOTHERAPY

DESCRIPTION: (Applicant's Description) This grant application seeks financial support for a Seventh and Eighth Conference on Radioimmunodetection and Radioimnunotherapy of Cancer, to be held in Princeton, New Jersey, October 15-17, 1998 and October ,19-21, 2000. This conference has been occurring every 2 years since 1988, and represents the only meeting of its kind which handles, in depth, all relevant topics concerning the use of radiolabeled antibodies (and smaller targeting molecules) for imaging and treatment of cancer. These topics include: radiochemistry of antibodies, physics and dosimetry of radiolabeled antibodies, radiation biology, experimental studies of targeting with monoclonal antibodies, clinical studies of radioimmunodetection of cancer, experimental and clinical radioimmunotherapy, reengineering of monoclonal antibodies, and new approaches to monoclonal antibodies and other tumor-targeting molecules. In addition to invited speakers presenting short overviews, oral presentations and posters of new findings will be the prime focus of the conference. At the conclusion or outset of each topic, the session chairperson will summarize the advances and problems of the topic covered. The proceedings of the conference will be published as a supplement to a major cancer immunology/radiopharmacy journal, such as Cancer Research or Cancer, within one year of the meeting, and all submissions are peer reviewed in accordance with the Journal's policies.